New Therapies for Essential Tremor from Cannabidiols Mechanisms

Project Summary/Abstract
Essential tremor affects 0.5-0.9% of the general population and about 4.5% above age 65.
Medications for tremor are re-purposed drugs found empirically, often lack potency, and are often not well
tolerated. In our program we study how drugs that suppress tremor work and through what molecular
targets. Many patients report that cannabidiol suppresses tremor. Cannabidiol is non-psychotropic and
has shown clinical efficacy for epilepsy, but may cause adverse effects, and induces hepatic enzymes.
More effective and well-tolerated medications for tremor, based on cannabidiol’s mechanism, are
desirable.
To assess tremor in mice, we use the harmaline tremor model, which has many similarities to essential
tremor. Our pilot data indicate that cannabidiol robustly suppresses harmaline-induced tremor, consistent with
clinical observations. Cannabidiol has many actions, but the main receptors activated by it directly or indirectly
are cannabinoid receptors type 1 and 2, the type 1 vanilloid receptor, and the serotonin type 1a receptor. By
co-administering specific receptor antagonists along with cannabidiol, it is possible to determine the
mechanism of action. In pilot experiments we found that activation of vanilloid 1 and serotonin 1a receptors
both mediate cannabidiol's anti-tremor effect. As a vanilloid 1 agonist suppresses tremor, an effect blocked by
a serotonin 1a receptor antagonist, it appears that vanilloid 1 receptor activation by cannabidiol is upstream to
serotonin 1a receptor-mediated tremor suppression. In Aim 1 we will seek to replicate these findings and, also
find out whether mice lacking the serotonin 1a receptor (knockouts) fail to show tremor suppression by
cannabidiol or the vanilloid 1 receptor agonist.
Much of cannabidiol's mechanism is due to inhibition of fatty acid amide hydrolase, leading to elevation of
the endogenous cannabinoid anandamide, which then activates several receptors. We found in pilot
experiments that a drug that inhibits this enzyme also suppresses tremor, an effect that requires both vanilloid
1 and serotonin 1a receptor activation. This suggests that inhibitors of fatty acid amide hydrolase could be
used clinically to treat tremor. In Aim 2 we will seek to replicate these findings, using drugs and knockout mice
to explore the role of vanilloid 1 and serotonin1a receptors in tremor suppression through inhibition of this
enzyme and also assess whether anandamide administration suppresses tremor through the same
mechanisms.
An important potential tremor therapy stemming from cannabidiol's mechanisms is the administration of
drugs that activate serotonin 1a receptors, which generally inhibit neuronal firing. When located on serotonin
cell bodies, serotonin 1a autoreceptor activation reduces cell firing and serotonin release, thereby reducing
activation of excitatory post-synaptic serotonin 2a receptors. Post-synaptic serotonin 1a receptors play a role
in antidepressant and other actions. In pilot studies we found that both autoreceptor- and postsynaptic-
preferring serotonin 1a agonists suppress tremor, while a drug that stimulates both receptors was even more
effective. In Aim 3 we shall replicate these experiments and, also determine whether repeated dosing causes
any of these serotonin agonists to lose their ability to suppress tremor. We will test them in serotonin 1a
knockout mice to confirm that they are in fact suppressing tremor by activating the serotonin 1a receptor.
This program is expected to lead to the identification of new therapies for essential tremor: inhibitors of
fatty acid amide hydrolase, anandamide-like drugs, and serotonin 1a receptor agonists. These therapies
are anticipated to be potent and well tolerated, should be available soon for clinical trials, and may also be
beneficial for anxiety and depression, conditions that are common in Veterans with essential tremor.

Public health relevance
Essential tremor is a common neurological disorder that is often disabling, interfering with daily tasks, and forcing early retirement. Many Veterans with tremor also have anxiety and depression. Current therapies are unsatisfactory. Our initial goals are to confirm our findings that cannabidiol suppresses tremor in the harmaline mouse model of essential tremor, and that a specific enzyme inhibitor that raises the brain level of a natural endocannabinoid also suppresses tremor. Our pilot data indicate that these agents work by activating a specific serotonin receptor subtype. We will seek to confirm out pilot findings that drugs that selectively activate these serotonin receptors suppress tremor and, also study how well they are tolerated and whether their effectiveness wears off. This work will facilitate the development of new therapies for disabling tremor in Veterans that are expected to be potent yet well tolerated. Moreover, based on published data, these treatments are expected to be effective for co-morbid depression and anxiety.